2013 Myogenesis Gordon Research Conference and Gordon Research Seminar

DESCRIPTION (provided by applicant): This proposal requests partial support for an international meeting on Myogenesis as part of the Gordon Research Conference and Gordon Research Seminar series to be held at the Renaissance Tuscany Il Ciocco Resort Lucca (Barga), Italy July 6-12, 2013. The broad and long term goal of the conference and seminar is to increase our understanding of the fundamental mechanisms of normal muscle development, growth and hypertrophy, regeneration, homeostasis and aging, cancer and myopathies, and evolution with an emphasis on mammalian models but with comparisons to other vertebrate and invertebrate systems. The specific aims of these meetings are to convene, in an isolated setting, 1. a Conference with 45 speakers that represent critical areas of striated muscle research with a total of 200 participants for a five day conference as well as 2. a one day graduate and postdoctoral research Seminar immediately prior to the Conference. The Conference program will have a keynote address on musculoskeletal development and evolution, and nine sessions that broadly address current issues in early muscle development, cell biological control of myogenesis, tissue interactions regulating muscle development and regeneration, regulation of muscle size, muscle stem cells, genetic, epigenetic, and microRNA control of muscle, muscle regeneration and aging, and muscle disease and treatments. In addition, four evening poster sessions will permit all participants to contribute to these topics. The Seminar will have four sessions of talks and two poster sessions by graduate students and postdoctoral fellows and represents a unique opportunity for the upcoming generation of scientists to present their research on myogenesis, develop new ideas, and form collaborations. The significance of this application is that the Myogenesis Gordon Research Conference is a critical component of the yearly series of conferences that bring together cutting edge muscle researchers in the international community. The inaugural Gordon-Kenan Graduate and Postdoctoral Research Seminar is an exciting new meeting to foster the upcoming generation of scientists in the field of myogenesis. The health relatedness of this application is that the discussions generated within this interdisciplinary conference will define current outstanding questions in the field and will generate new experimental approaches in areas that affect human muscle development, health, and aging, muscle diseases, and regenerative mechanisms and therapies.

Public health relevance
The 2013 Gordon Research Conference on New Horizons in Myogenesis will bring together 45 speakers that represent critical areas of striated muscle research with a total of 200 participants for a five-day conference focusing on increasing our understanding of fundamental mechanisms of normal muscle development, growth and hypertrophy, regeneration, homeostasis and aging, cancer and myopathies, and evolution with an emphasis on mammalian models but with comparisons to other vertebrate and invertebrate systems. The health relatedness of this application is that the discussions generated within this interdisciplinary conference will define current outstanding questions affecting human muscle health, by in-depth exploration of mechanisms regulating muscle development, homeostasis, and aging, muscle disease, regeneration and repair, leading to new therapies based on these mechanisms.